International Conference on Learning and Memory

ABSTRACT Neurological and neuropsychiatric illnesses are prevalent and debilitating, affecting more than a quarter of the global population. Learning and memory are implicated in every neurological illness from stroke to Alzheimer’s disease and every neuropsychiatric dysfunction from depression to drug addiction. Understanding the neuroscience of learning and memory, integrating across approaches and methods, is one of the most formidable challenges of the 21st century. While research in these areas has made significant strides in understanding and treating brain disease as well as promoting brain health, progress has been stalled. There are fundamental gaps in our knowledge that stem for lack of integration across approaches and insufficient dialogue among investigators addressing neuroscience questions from different perspectives. Integration across animal and human research as well as basic and clinical research will have substantial impact on facilitating team science, which is essential for successful translation. The 2018 International Conference on Learning and Memory (LEARNMEM2018) covers numerous facets of the neuroscience of learning and memory with an emphasis on integrating across animal and human studies as well as across fundamental and translational science. The 5-day conference that will feature plenary and keynote talks by distinguished neuroscientists, diverse and balanced symposia, short talks, poster sessions, a panel discussion on open science and open publishing, as well as community engagement sessions. Anticipated attendance is ~800 and the conference is open to everyone. AMA PRA Category 1™ Continuing Medical Education (CME) credits will be offered to physicians and healthcare professionals. Travel awards for early career scientists will be available, and special emphasis will be placed on multidimensional diversity of contributions across gender, race, seniority, country of origin, and level of analysis. The conference will achieve the following aims (1) Identify knowledge gaps and opportunities for scientists, clinicians, nonprofits, businesses, and community members to share and discuss cutting-edge research in the area of learning and memory; (2) Form collaborative teams among domestic and international investigators, early career and established scientists, animal and human researchers, fundamental and translational scientists, as well as user and developer communities; (3) Disseminate knowledge generated from the meeting through scientific and public venues; and (4) Facilitate engagement between scientists and community members across all levels from schoolchildren to retirees. LEARNMEM2018 will have substantial impact on the field by accelerating the pace of team science and leapfrogging towards a more complete fundamental understanding of learning and memory mechanisms as well as novel therapeutic and preventative approaches to treating brain illness and promoting brain health.

Public health relevance
PUBLIC HEALTH NARRATIVE Neurological and neuropsychiatric illnesses are prevalent and debilitating, affecting more than a quarter of the global population. Learning and memory are implicated in every neurological illness from stroke to Alzheimer’s disease and every neuropsychiatric dysfunction from depression to drug addiction. Understanding the neuroscience of learning and memory, integrating across approaches and methods, is one of the most formidable challenges of the 21st century.